Applied Curriculum in Women's Health and Social Systems (ACES)

Recognizing that effective implementation of health programs requires attention to sex-based differences and the integration of sex-disaggregated analysis, the Applied Curriculum in Women’s Health and Social Systems (ACES) will develop an applied educational program to strengthen research and implementation skills related to sex-based and social analysis in health globally. ACES will pilot and implement this curriculum through an online Summer Institute at Johns Hopkins University and will sustain a community of practice of specialists by leveraging existing external and internal networks.
Building on existing successful courses in women’s leadership, women’s health, and research methods, ACES will offer a series of short, intensive, online courses through an Accelerated Learning Institute at the Bloomberg School of Public Health. These courses will focus on applied approaches such as using data to improve health outcomes, designing interventions, budgeting with attention to social factors, conducting situational analyses that consider women’s health needs, monitoring and evaluation practices that reflect sex-based data, and communication and advocacy strategies to improve the health of women, girls, and other groups.
The curriculum will be grounded in real-world challenges, informed by current scholarship, and taught by a faculty of leading experts in the field. It will serve current and future public health professionals from the U.S. and globally who seek practical skills to address sex-related and social determinants of health in program design and implementation. The training will enhance participants’ qualifications for roles in government, non-profit, and academic sectors focused on improving health outcomes through evidence-informed strategies.

Public health relevance
JOHNS HOPKINS ACES Johns Hopkins Bloomberg School of Public Health will develop an Applied Curriculum in Women's Health and Social Systems (ACES) in order to increase skills and competencies in applied social systems methods among current and future health professionals. ACES will develop, pilot and implement a series of short, intense, online courses to provide training with particular focus on applied methods including using sex-disaggregated data to improve health outcomes and design contextually appropriate interventions, conducting situational analyses with attention to sex and social systems, applying responsive monitoring and evaluation frameworks, and developing skills in communication, advocacy and budgeting for women’s health programming.